Oklahoma Rheumatic Disease Research Cores Center (Overall Application)

Oklahoma Rheumatic Disease Research Cores Center: Overall Project Summary
The Oklahoma Rheumatic Disease Research Cores Center (ORDRCC) unites 25 established Center
Investigators, 22 junior center investigators (11 within and 11 outside Oklahoma) and a newly proposed
Reichlin/Capra Scholar program to develop early-stage investigators with outstanding promise in rheumatic
disease research. The mission of the ORDRCC is to optimize interactions between basic, clinical and analytic
scientists focused on deciphering pathogenesis, prediction, prevention and precision therapeutic selection in
rheumatic disease. As the foundation for this mission, the ORDRCC has developed some of the largest
existing cross-sectional and longitudinal collections of SLE, Sjogren’s, and rheumatoid arthritis. With a CAP-
certified Biorepository and electronic clinical research management system, the ORDRCC continues to expand
these large, well-characterized collections and to build others in osteoarthritis, undifferentiated connective
tissue disease and autoimmune rheumatic disease pregnancies. The ORDRCC-supported collections and
biorepository infrastructure are critical resources for many established rheumatic disease investigators and
inter-institutional rheumatic disease collaborations, and have helped launch the independent careers of 27
former New Investigators. Without ORDRCC support, these collections would be unavailable, as would the
basic infrastructure that enables the Biorepository to serve several NIH-sponsored and other investigator-
initiated clinical trials at a fraction of the cost of a commercial biorepository. The Clinical Characterization and
Biorepository Core (CCBC) which houses these collections, also provides clinical research units to aid in study
recruitment, regulatory assistance for junior investigators and Scholars, and translational informatics to help
visualize complex datasets of clinical and molecular data. The newly revised Human Phenotyping Core (HPC)
empowers ORDRCC investigators to use the latest high-content phenotyping methodologies for precision
medicine approaches by providing experienced technical personnel, proven standard operating procedures
and training for sample preparation, assay development, data QC, and analytical assistance. The HPC helps
ORDRCC investigators perform and analyze high-dimensional cytometry, single-cell transcriptomics and
proteomics, high-content flow cytometry for functional immune response assays, molecular phenotyping by
transcriptomics, and high-throughput testing of soluble biomarkers. Together the CCBC and HPC will integrate
clinical and molecular information to identify molecularly homogeneous subsets of subjects for studies or trials.
The Administrative Core serves as the central management and communication hub for the ORDRCC and
coordinates a multi-disciplinary enrichment program, including a Rheumatic Disease Research Forum, a
vibrant and successful Pilot Projects program, a new Proposal Development Core to assist investigators with
developing robust manuscripts and competitive grant applications and a new Expanding Rheumatic Disease
Research Colloquium to forge interactions between ORDRCC scientists and investigators from other fields.

Public health relevance
Overall Project Narrative Despite the prevalence of rheumatic diseases, their molecular causes are poorly understood and many diseases lack effective diagnostics, prognostics, and treatments. To overcome this public health burden, the Oklahoma Rheumatic Disease Resources Cores Center provides mentoring, training, clinical research infrastructure access to clinical samples and data, access to expert consulting and high-end technology resources required to comprehensively investigate the molecular changes associated with rheumatic diseases and to uncover new disease mechanisms, therapeutic targets and clinically informative biomarkers. Our Center supports a growing group of over 200 rheumatic disease investigators, locally, nationally and internationally, through direct or indirect support.